Non-viral genome, epigenome, and transcriptome engineering for clinical CAR-T cell manufacturing

PROJECT SUMMARY / ABSTRACT
The goal of this application is to train Dr. Brian Shy, a physician scientist at the University of California San
Francisco, with the skills necessary to become an independently-funded investigator studying, developing, and
manufacturing engineered cellular therapies. This research proposal will evaluate CRISPR-based non-viral
methods for targeted genome, epigenome, and transcriptome engineering in primary human T cells. This will be
applied to understand DNA repair pathway choice and DNA toxicity responses in order to improve site-specific
“knock-in” strategies with large therapeutic constructs such as chimeric antigen receptors (CARs), develop safe
and efficient methods for multiplexed T cell modifications, and establish Good Manufacturing Practice (GMP)
compatible processes for clinical implementation of this diverse toolset. This research is accompanied by a
career development and training plan that will build on Dr. Shy's clinical training in Transfusion Medicine and
Cellular Therapy, and his prior expertise in the pre-clinical development and manufacturing of experimental
cellular therapies. Training will focus on 1) implementation of novel cellular engineering tools, 2) next generation
sequencing (NGS) technologies and analysis of large datasets, 3) GMP manufacturing and pre-clinical
development, 4) clinical trial design and standard-of-care cellular therapies, and 5) laboratory management,
grant writing, presentation, and research strategy skills. This career development and training plan will include a
combination of formal coursework, mentored practical training; conference, meeting, and workshop attendance;
and guidance from an exceptional team of co-mentors, advisors, and collaborators. Altogether, this award will
help prepare Dr. Shy for an independent research career focused on developing improved cellular therapies for
treatment of cancer and other human diseases.

Public health relevance
PROJECT NARRATIVE CRISPR-based T cell engineering offers unprecedented opportunities to reprogram cellular functions in order to develop advanced cell therapies that improve cancer outcomes and expand patient access. This project will implement a diverse CRISPR toolset for genome, epigenome, and transcriptome modification to understand critical parameters affecting primary human T cell engineering outcomes, and will incorporate these tools within a multiplexed and clinically-compatible T cell manufacturing pipeline to develop safer and more effective cancer therapies.